Family Study of Carotid Atherosclerosis and Stroke Risk

Project Summary
Stroke is the leading cause of death and disability in the US and disproportionally affects minority populations.
Hispanics have a particularly high risk for stroke; this increased risk of stroke may be explained by specific genetic
and non-genetic factors. Dominicans are the fastest growing Caribbean Hispanics in the US, and yet little is known
about their genetic and non-genetic determinants of stroke and cardiovascular disease (CVD). For the past 15
years, our team has been investigating stroke genetic risk factors in Dominicans. We have assembled a cohort
of Dominican families at high risk of stroke and focused on stroke precursor phenotypes (SPPs) to reduce
phenotypic heterogeneity and complexity of stroke etiology. We investigated well-recognized SPPs including
carotid intima-media thickness, carotid plaque, left ventricular mass, and left atrial diameter. We have
successfully identified quantitative trait loci and DNA sequence variants associated with SPPs using high
throughput genotyping and next generation sequencing. These findings account for a small portion of the inter-
individual variation in SPPs. In this application, we propose to expand our investigations to conduct a methylome-
wide-association-study (MWAS) to identify differential DNA methylation regions (DMRs) associated with SPPs,
stroke and CVD. Methylation is an epigenetic process that regulates gene expression without changing DNA
sequence. DNA methylation has been shown as a key process contributing to the development of vascular
disease. The proposed investigations would provide new insights relevant to the development of novel clinical
strategies for prevention and treatment of stroke and CVD, as our ultimate goal is to reduce stroke risk and race-
ethnic disparities in stroke and CVD. We plan 4 aims: Aim 1 to identify DMRs associated with stroke SPPs; Aim
2 to assess the relative contribution of genetic and non-genetic factors to SPP-associated DMRs; Aim3 to
evaluate the functional impact of DNA sequence variation and DMRs using CRISPR-Cas9 technology; and Aim
4 to examine the predictive effect of SPP-associated DMRs on vascular events. To achieve these aims we will
leverage the rich data already collected in the Family Study and add new data collection to detect vascular events
(stroke, myocardial infarction, vascular death). We will validate the findings in an independent sample from the
ongoing longitudinal Northern Manhattan Study, from which the Family Study originated. Both studies have used
the same assessment tools and collection instruments for obtaining SPPs, lifestyle risk factors and genome-wide
SNP data. The innovative aspects of our proposal include novel discoveries of modifiable epigenetic sites for
stroke and CVD, CRISPR-Cas9 technology to model specific genome-editing, a unique population of Dominicans
and a family study design, and an available independent population of Dominicans for validation studies.
Findings from our study may lead to the most promising molecular strategies for risk stratification, prevention
and treatment of stroke.

Public health relevance
Project Narrative Stroke is a major public health problem that disproportionally affects Hispanics. For over 15 years, we have been investigating genetic risk factors for stroke in Dominicans, one of the fastest growing sub-populations of Hispanics in the US. We propose an epigenetic study using our established Dominican cohorts. Findings from our study may lead to novel molecular strategies for risk stratification, prevention and treatment of stroke.